Calpain-mediated lung endothelial barrier modulation in acute lung injury

Summary
Acute lung injury (ALI) is characterized by lung vascular endothelial (EC) barrier compromise resulting in
increased EC permeability and pulmonary edema. The infections of Gram negative bacteria compose the major
cause for ALI. Little has been known about how Gram negative endotoxins (i.e. lipopolysaccharides, LPS) induce
EC barrier disruption. We found that LPS activates endopeptidase, calpain, in human lung microvascular ECs
(HLMVECs) and the specific calpain inhibition prevents LPS-induced disruption of EC barrier function of
HLMVECs and LPS-induced pulmonary edema in ALI. Calpain is a family of calcium-dependent non-lysosomal
neutral cysteine endopeptidases that act via limited proteolysis of substrate proteins in mammalian cells,
including HLMVECs. Our preliminary data show that LPS induces talin cleavage into head and rod domain and
talin phosphorylation in HLMVECs and that overexpression of calpain causes talin cleavage and RhoA activation
and myosin light chain phosphatase (MLCP) phosphorylation resulting in MLCP inhibition and myosin light chain
(MLC) phosphorylation. Talin is activated through talin cleavage or phosphorylation. Talin cleavage separates
head from rod domain thus removing auto-inhibition and stimulating talin head binding to integrin and thus
induces FA activation, leading to RhoA activation and MLCP inhibition and MLC phosphorylation and increased
lung EC permeability. Talin activation through phosphorylation at Ser-425 can be through cyclin-dependent
kinase 5 (CDK5). Our data show that calpain inhibition attenuates LPS-induced increase in CDK5 activity and
that MLCP is involved in talin dephosphorylation. This proposal is to study a novel hypothesis that calpain/MLCP
coordination regulates talin activation (cleavage/phosphorylation) leading to endothelial barrier disruption in ALI.
We will determine whether Gram negative endotoxin LPS, E. coli and P. aeruginosa induce calpain activation
and calpain leads to lung microvascular endothelial barrier disruption and Rho-mediated MLCP
phosphorylation/inhibition and MLC phosphorylation in ALI. We will define whether LPS, E. coli and P.
aeruginosa induce talin activation (cleavage/phosphorylation) and FA strengthening, leading to lung
microvascular endothelial barrier disruption in vitro and in vivo. We will investigate whether calpain regulates
talin activation (cleavage/phosphorylation) in lung microvascular endothelial barrier disruption in ALI induced by
LPS, E. coli and P. aeruginosa. We will assess whether plasma from ALI patients with Gram negative sepsis
induces HLMVEC barrier compromise via calpain-talin-FA-MLCP pathway. This proposal is novel because it will
identify calpain as mediators in lung EC barrier compromise and calpain serves this role by regulating novel talin
cleavage/phosphorylation, RhoA activation and MLCP activity in ALI. A better understanding of the mechanistic
insight will provide a framework from which novel calpain inhibition and MLCP activation strategies can be
developed for intervention and treatment of ALI.

Public health relevance
Acute respiratory distress syndrome (ARDS) is a common and life-threatening cause of acute respiratory failure affecting Veterans more than non-Veteran population. It is also a common complication among military casualties in combat. It is a pressing problem for Veterans and current estimates suggest that more Veterans will die from ARDS each year than from lung cancer. Thus, it is very important to understand the mechanism of ARDS. This proposal will determine the mechanism of lung vascular barrier disruption in acute lung injury associated to ARDS. Completion of this project will help find novel treatments for ARDS and in turn improve the life and care of Veterans.